Refinement and Pilot Testing of a Computerized Distress Tolerance Intervention with Just-In-Time Text Message Reminders for Cannabis Use Disorder

Project Summary. The prevalence of daily cannabis use and Cannabis Use Disorder (CUD) has increased in
the United States over the past two decades. Brief, computerized harm reduction interventions that target
specific high-risk CUD populations could be an efficient approach to reducing CUD. Distress intolerance (DI),
which refers to the tendency to negatively appraise and escape aversive emotional states, is a risk factor
associated with stress-related cannabis use motivation and CUD severity/chronicity. Thus, a brief, accessible,
low-cost intervention that reduces DI in those with CUD and elevated DI could have a significant public health
impact. This proposed Stage I project aims to modify an existing two-session computerized distress tolerance
intervention to optimize emotion regulation learning/generalization and test its impact on DI and cannabis use
outcomes in a randomized controlled trial. Specifically, the intervention will be condensed to one-session and
its imaginal exposure module will be modified to shape emotional engagement with the aim of maximizing
within-session habituation, which will be signaled with a novel audio/visual cue (habituation cue). Habituation
cues will then be delivered in just-in-time text message reminders triggered by naturalistic distress reported via
ecological momentary assessment. After obtaining feedback on the modified Emotional Engagement Distress
Tolerance Intervention in a small sample (Specific Aim 1), the intervention’s efficacy compared to a stringent,
credible, time-matched health education control intervention will be tested in a randomized controlled trial in 80
cannabis users with CUD and high DI. To measure the intervention’s mechanistic target engagement (Specific
Aim 2), multi-method DI assessments will be administered through four-month follow-up. To measure the
intervention’s impact on cannabis use (Specific Aim 3a), stress-related cannabis use motivation (lab stress-
elicited craving and neurophysiological drug cue reactivity, ecological momentary assessment of stress-elicited
cannabis use) will be assessed through the intervention period. Interviewer-assessed cannabis use frequency,
CUD severity, and urinary THC metabolite concentration will be measured through 4-month follow-up. Quality
of life and anxiety/depression symptoms will also be measured as secondary outcomes through 4-month
follow-up (Specific Aim 3b). As an exploratory aim, a wristworn device will be used to measure ambulatory
physiology during a portion of the intervention period to evaluate the feasibility of detecting heightened real-
world distress based on objective indicators (Specific Aim 4).Our central hypothesis is that, compared to a
control intervention, the Emotional Engagement Distress Tolerance Intervention will produce superior
reductions in multi-method assessments of DI, stress-related cannabis use motivation, disordered cannabis
use, and psychosocial functioning. Successful completion of the proposed aims will (1) justify a subsequent
Stage II trial, and (2) inform efforts to integrate the just-in-time habituation reminders with wearable technology
in order to increase emotion regulation generalization opportunities and decrease participant report burden.

Public health relevance
Project Narrative. This project is relevant to public health because it represents a novel, targeted harm reduction approach to the treatment of Cannabis Use Disorder, a major public health concern in the era of increasing cannabis legalization. This study aims to evaluate the effect of a one-session computerized distress tolerance intervention with just-in-time text message support on distress tolerance, stress-related cannabis use motivation, disordered cannabis use, and psychosocial functioning, representing a highly portable, low-cost solution to the problem of Cannabis Use Disorder.